Retroviral Integration & HDAC inhibitors

DESCRIPTION (provided by applicant): A key goal of retroviral-based gene delivery is to maximize gene expression without the complication of insertional mutagenesis. The studies in this proposal examine the linkage between integration and gene expression. This new area of investigation is based on the observation that mutations within the Moloney murine leukemia virus integrase (M-MuLV IN) proteins can be compensated by the presence of histone deacetylase (HDAC) inhibitors at the time of integration. The results highlight a new function of the IN protein beyond integration, namely the regulation and establishment of the epigenetic state of the proviral DNA. In a wild type MuLV infection, viral expression is suppressed until after integration, which results in highly expressed gene products. Analysis of mutations within the MuLV IN C-terminal domain (CTD) reveals a phenotype that has lost this tight regulation. Although replication and integration of the K376R mutant is equivalent to WT IN, the expression from the integrated virus is minimal. Experiments aim at defining how the IN protein is involved in the early establishment of short-term gene expression from the provirus. Additional experiments aim at defining the normal mechanism of transcriptional repression from unintegrated DNA. The role of the IN protein and the intasome in repressing the LTR enhancer/promoter regions will be studied. The relationship of the promoter with respect to the viral termini will be examined. Additional studies aim at manipulating the expression from the unintegrated virus. The final specific aim provides structural/functional analysis of the IN CTD. Two collaborative projects have been established. The first examines the role of host proteins to interact with the MuLV IN CTD. The second is a NMR structural study of the MuLV IN CTD. These studies have direct application to multiple areas of vector development. The ability to establish efficient expression from unintegrated proviral DNA can be rapidly translated to the field of induced pluripotent stem cell (iPS). In addition, the ability to manipulate the short and long-term expression from integrated retroviral vectors has been a major shortcoming for gene transfer. Understanding the role of the IN protein in establishing this epigenetic state is a new and significant area for gene delivery.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long-term safety of murine-based retroviral vectors is directly linked to the integration target site and the activation of the viral enhancer sequences. This application studies the link between retroviral integration and gene expression. The experiments build on the observation that mutant murine leukemia virus integrase proteins can be compensated by the presence of histone deacetylase inhibitors. Defining the mechanism of this complementation and optimizing the vector design can result in novel vectors with broad applications for gene delivery and stem cell biology. The long-term safety of murine-based retroviral vectors is directly linked to the integration target site and the activation of the viral enhancer sequences. This application studies the link between retroviral integration and gene expression. The experiments build on the observation that mutant murine leukemia virus integrase proteins can be compensated by the presence of histone deacetylase inhibitors. Defining the mechanism of this complementation and optimizing the vector design can result in novel vectors with broad applications for gene delivery and stem cell biology. __SpecificAimsTextDelimiter__ a. Specific Aims: These studies open a new area of investigation for the laboratory-the linkage between retroviral integration and transcription. For simple retroviruses, loss of the viral integrase (IN) blocks the viral life cycle and subsequent transcription of vRNA. Research from our laboratory has recently shown that mutations in the C-terminal domain (CTD) of the Moloney murine leukemia virus (M-MuLV) IN protein has two effects: 1) the first is that they can be complemented by the addition of histone deacetylase (HDAC) inhibitors leading to viral expression and 2) although integration levels and target-site selection is not altered, the integrated viruses are repressed for expression. The aim of this proposal is to investigate the interrelation between these two basic viral-associated processes-integration and expression. These studies have profound effects on retroviral gene delivery and vector development. The results imply that the IN protein has a direct effect on the establishment of the epigenetic/transcriptional state of both the unintegrated and integrated proviral DNA. The results have direct implications to the field of non- integrating retroviral vectors, a developing area with applications for stem cells and gene delivery to non- dividing cells. Areas of investigation are summarized below. 1. What is the normal mechanism of transcriptional repression from unintegrated DNA? In wildtype MuLV infection, virus lacking the IN protein are not infectious, indicating that expression from the unintegrated virus does not maintain virus viability. The preintegration complex (PIC) forms a structure called the intasome. The defining characteristic of the intasome is that the termini of the linear unintegrated DNA are found in a condensed protected conformation. Proteins contributing to the intasome include the IN protein as well as the cellular protein BAF (barrier to autointegration factor). The intasome thus could affect integration, as well as transcription, through protection of the viral enhancer regions located in U3 of the LTR. Experiments to systematically examine the effects of altering the distance of the promoter/enhancer regions from the viral termini are proposed, through the use of insulators, SIN vectors and internal promoters. 2. Can we manipulate expression from the unintegrated proviral DNA? Analysis of MuLV IN CTD mutants indicate that transient expression of the viral genome can be activated by HDAC inhibitors with time courses corresponding with the presence of the unintegrated proviral DNA. Experiments are aimed at analyzing and optimizing the TSA-responsive transcription. Analysis will include IN D184N mutants, that are catalytically inactive, as well as the IN CTD mutants. Expression from linears versus circular proviral DNA will be examined. Modified MuLV vectors capable of infecting non-dividing cells will also be studied. 3. Defining the epigenetic state of the integrated virus. The MuLV IN CTD mutants displayed a second phenotype indicating that the integration/transcription linkage is uncoupled. Quantitative analysis of the IN K376R mutant indicated that the level of integration as well as the target-site preference is not altered, however expression of marker genes from the viral LTR is greatly reduced. Studies aim at defining the mechanism of the repression of transcription from the integrated IN mutant provirus and its linkage to the IN protein. Experiments include analyzing the effects of TSA on target-site selection, the role of DNA methylation and analysis of the epigenetic state of the integrants using chromatin IP (ChIP) analysis. 4. Structure/function analysis of MuLV IN CTD. The IN protein can influence chromatin and transcription activation/repression through protein-protein interactions. Using a yeast-two-hybrid screen, specific interactors with the MuLV IN have been identified (16). The ability of the IN CTD mutants to maintain these protein-protein interactions will be examined. The role of post-translational modifications on the IN function will also be analyzed. To date, there is no structural information on the MuLV IN CTD domain. The MuLV IN CTD bears a unique insertion distinct from the CTD of HIV and avian retroviruses. Using a novel method to express and label proteins in bacteria, the structural studies of the MuLV IN CTD will be performed in collaboration with Dr. Guy Montelione.